Developmental disruption of brain tissue oxygen regulation and deficiency of learning after neonatal anesthesia exposure

Each year, millions of people, including six million children, undergo general anesthesia
for surgeries, medical imaging, and other procedures. The potential negative effects of
anesthesia on the developing brain are concerning, as they may lead to later learning
and behavioral deficits. Currently, there are limited instrumental methods available for
diagnosing and predicting anesthesia-induced disabilities, as well as limited treatment
options. However, transcranial magnetic and electric stimulation (TMES) is an
established, non-invasive method that enables the assessment of the excitatory and
inhibitory properties of the brain. In addition to its diagnostic role, specific modalities of
TMES can produce long-lasting changes in local brain excitability by stimulating
neuronal plasticity and synaptogenesis. It is expected that TMES will aid in both
diagnosing and treating disabilities related to anesthesia exposure during childhood.

Public health relevance
Transcranial magnetic and electric stimulation is an established non-invasive method that allows for the assessment of excitatory and inhibitory properties of the brain, as well as the stimulation of neuronal plasticity. This method is expected to help improve brain function in children who have been exposed to neonatal anesthesia.